Intracellular signaling in airway solitary chemosensory (tuft) cells

Project Summary
Airway tuft cells (also known as “brush” or “solitary chemosensory” cells) are rare cells found in the
nose and trachea. Tuft cells are also found in the lung after injury and/or inflammation or in genetic diseases
like primary ciliary dyskinesia. Tuft cells regulate local antimicrobial peptide, acetylcholine (ACh), and IL-25
secretion. IL-25 is an important driver of Th2 inflammatory responses observed in airway disease like
chronic rhinosinusitis (CRS) with nasal polyps and asthma. Tuft cell ACh may activate sensory neurons
and/or local mucociliary or inflammatory responses.
We know little about how to target tuft cells in airway diseases, because we know little about human
tuft cell function. Their rarity (≤1 in 100 cells in the nose) makes them difficult to study, though their
frequency increases significantly (up to 30% of the epithelium) in nasal polyps. We know that tuft cells
express a range of chemosensory G protein-coupled receptors (GPCRs) but know little about how they
signal and regulate cell responses. We previously showed that activation of T2R bitter taste GPCRs
stimulates Ca2+ -driven secretion of antimicrobial peptides from surrounding epithelial cells. This response is
inhibited by activation of cAMP downstream of T1R sweet taste GPCRs, which sense airway surface liquid
glucose or sweet bacterial D-amino acids. Other GPCRs (e.g., succinate, cholinergic receptors, adenosine
receptors, etc.) exist in tuft cells, but their functions are less clear. Many studies have been done in mice,
but our research revealed differences in how mouse vs human tuft cells signal. We need better methods for
studying human tuft cell function to complement and extend prior mouse studies.
The goal here is to identify the signaling and downstream consequences of nasal tuft cell GPCRs,
which may be important therapeutic targets for respiratory infections, either to enhance antibacterial
immunity or reduce nasal/lung inflammation. We will utilize a novel genetic labeling strategy to express
fluorescent protein biosensors specifically in human tuft cells cultured from residual nasal surgical material.
This allows optical imaging of tuft cell function within an intact epithelial monolayer differentiated at air-liquid
interface. In Aim 1, we will use these methods to study how tuft cell GPCRs regulate Ca2+, cAMP, and other
pathways to fine tune antimicrobial peptide secretion. In Aim 2, we will study how these pathways regulate
electrical excitability of airway tuft cells and if/how membrane voltage changes contribute to tuft cell
responses. In Aim 3, we will elucidate mechanisms of how tuft cells secrete/release ACh and IL-25 in the
context of Th2 iairway disease. These data will clarify the regulation of intracellular signaling of human tuft
cells to better understand how to target them in airway diseases like CRS and possibly asthma.

Public health relevance
Project Narrative When you inhale harmful bacteria or fungi, they can stimulate airway tuft cells found interspersed throughout the nasal cavity and sometimes in the lungs. Tuft cells activate antimicrobial and inflammatory responses that might be useful to pharmacologically target in diseases like chronic rhinosinusitis or asthma. The goal here is to determine how the receptors in these tuft cells are activated and regulate tuft cell function to understand how we can leverage them to treat airway diseases.